Metabolism Core

ABSTRACT – Core C
The ability to maintain metabolic and redox homeostasis is at the center of muscle health and degeneration.
The Metabolism Core will provide access to unique state of the art tools to quantify altered metabolism and
mitochondrial function in skeletal muscle. Disruption of energy homeostasis due to mitochondrial dysfunction is
a key mechanism controlling diverse cellular processes that can lead to muscle degeneration, including the
balance between protein synthesis and degradation, contractile function, E-C coupling, and apoptosis. The
Metabolism Core will provide an integrative approach to analyze the role of changes in metabolic and
mitochondrial function in skeletal muscle dysfunction to a broad user base. We have developed state of the art
tools that include global and targeted metabolomics, magnetic resonance and optical spectroscopy, and
biochemical analyses of isolated mitochondria and permeabilized fibers that will provide vastly improved and
detailed insights into muscle biology, and an ability to monitor therapeutic approaches at the molecular level.
The goal of this core is to expand access to these tools and expertise for experimental design, data collection,
analysis, and interpretation to address the role of metabolism in skeletal muscle health and dysfunction. Aim 1
will provide a broad array of targeted and global metabolomic and lipidomic analyses from skeletal muscle
biopsy, ligaments and tendons, as well as biofluids and related biological samples. Aim 2 will provide state of
the art analyses of in vivo mitochondrial capacty and quality (ATPmax and P/O) and muscle energety state
(PCr/ATP and ADP/ATP). Aim 3 will provide detailed biochemical analyses of oxidative phosphorylation and
mitochondrial oxidative stress in permeabilized muscle fibers and isolated mitochondria. These measurements
will provide an integrated picture of muscle metabolism, mitochondrial function and muscle energetics that can
be used to understand the mechanisms leading to protection or pathology in models of skeletal muscle disease.
The central role of metabolism connecting all aspects of muscle physiology will allow this Core to provide a
natural bridge between between the Mechanics and Devices and Quantitative Analysis Cores of the proposed
center.